Dissecting continuous phenotypic transitions in cellular states with novel quantitative experimental and computational methods

Project Summary
A central question in biology is how genetically identical cells generate diverse phenotypes. Cells often
respond differently to the same perturbation, emphasizing the key role of internal cellular states in shaping
these outcomes. Enhancing our ability to predict cellular behaviors could improve tissue regeneration,
accelerate drug discovery, and better anticipate drug resistance. To address this, my lab integrates
computational biology, systems biology, and cutting-edge genomic technologies to investigate how cellular
diversity arises from a single genome, with applications across ovarian aging, cardiovascular disease, and
hormone-dependent cancers.
This proposal aims to develop a new framework for studying the causal mechanisms driving continuous
phenotypic transitions in cellular states. By using PROTACs (proteolysis-targeting chimeras) as fast-acting
chemical perturbations, we will induce rapid protein degradation, and apply single-cell proteogenomics to
quantify how upstream biochemical changes lead to downstream gene regulatory changes. Compared to
CRISPR-based genetic screens, PROTACs provide a temporally precise observation of gene expression
changes before compensatory mechanisms emerge, providing clearer insights into causal relationships. This
approach will enable us to build next-generation predictive models for cellular responses, advancing both
fundamental biology and therapeutic development.
Additionally, we are developing P3-seq, a novel single-cell technology that simultaneously measures
intracellular proteins, protein-protein interactions (PPIs), and transcriptomes. PPIs are central to pathway
integration and cellular signaling networks, yet no scalable single-cell method for quantifying them exists. P3-
seq will provide deeper insights into how combinatorial protein interactions influence cellular outcomes—an
area that remains underexplored.
Over the next five years, our goal is to apply these discoveries to build predictive models that improve the
ability to precisely control cellular behaviors, particularly in response to therapeutic interventions.

Public health relevance
Project Narrative This proposal aims to develop a new paradigm for understanding how genetically identical cells respond differently to the same perturbation, such as drugs. By combining novel single-cell technologies and advanced computational methods, our goal is to quantify and model how variations in internal cellular states arising from biochemical processes drive downstream gene regulatory changes. The insights gained from this work have the potential to transform how we infer causal relationships within gene regulatory networks, ultimately improving predictive modeling for drug development and therapeutic strategies, leading to more effective and personalized patient care.